Non-Invasive Methods to Drive Neural Activity with Millisecond Precision and to Recruit the Brain’s Immune Cells

The parent grant has shown that non-invasive flickering sensory stimulation entrains multiple specific frequencies of neural activity and gamma frequency sensory stimulation recruits immune signals and cells microglia to engulf pathogenic proteins in mouse models for AD. In addition, the parent grant is actively investigating the effects of sensory stimulation on neural codes and synapses. The goal of this proposal is to determine which, if any, patterns of sensory flicker restore healthy synaptic and microglia functions following chronic stress. Individuals that have suffered from chronic or severe stress have a 2-fold or greater increased risk of developing AD. Loss of synaptic integrity is one of the best predictors of neuropsychiatric and cognitive decline in AD. Stress increases the risk of AD and associated neuropsychiatric symptoms by promoting synapses loss in corticolimbic brain regions due to enhanced synaptic pruning by dysfunctional microglia, the primary immune cells of the brain. Furthermore, mounting evidence suggests that chronic stress accelerates the progression of AD-associated pathology including the accumulation of aggregated amyloid-β (Aβ) peptide and amyloid plaques. Accordingly, we will determine if chronic sensory flicker exposure prevents stress-induced synaptic loss, accelerated amyloid accumulation, and microglia-mediated synapse remodeling in corticolimbic brain regions following chronic stress in WT and 5XFAD mice. This research will be the first to identify how stress-induced synaptic loss, accelerated pathology accumulation, and immune dysfunction is halted by flicker stimulation. Identifying the effects of flicker on stress-induced pathology will reveal a role for specific frequencies of neural activity on stress neurobiology and provide the foundation for using this non-invasive stimulation as a novel therapeutic approach to prevent stress-induced decline in AD. Because individuals are twice as likely to develop AD following chronic or severe stress, prevention of the neurobiological effects of stress would severely reduce the prevalence of AD.

Public health relevance
Individuals that have suffered from chronic or severe stress have a 2-fold or greater increased risk of developing Alzheimer’s disease. The parent grant has recently shown that non-invasive flickering sensory stimulation entrains neural activity, restores immune function, and reduces pathology in Alzheimer’s model mice across many brain regions. This research will determine how to use sensory flicker to prevent the neuropathological effects of stress and ultimately reduce the risk of Alzheimer’s.